NIAAA ALCOHOL POLICY INFORMATION SYSTEM APIS

The Alcohol Policy Information System (APIS) provides user-searchable access to authoritative, detailed, and comparable information on alcohol and cannabis-related public policies in the United States, at both State and Federal levels.